Mighty Girls and the Mighty Moment App: Leveraging Innovative Technology, Narrative Theory, and Social Media to Empower Young Girls to Resist Peer Pressure to Engage in Risky Behavior

The goal of this SBIR Phase I is to prevent risky sexual behaviors among young female adolescents in order to reduce negative outcomes such as early pregnancy and sexually transmitted infections. To accomplish this goal, we propose using state-of-the-art technology to develop a scalable and multicultural version of the efficacious Mighty Girls program and evaluate its usability and feasibility. Early sexual initiation remains costly to individuals, families, and society. However, development of effective sex education curricula for early adolescence has been inhibited by a lack of prevention science strategies and political issues. In answer to these challenges, Norris and Hecht/REAL Prevention created Mighty Girls (MG), a brief sexual-pressure resistance curriculum grounded in Social Cognitive Theory and the Communication Competence Model and guided by Narrative Engagement Theory. MG was developed with parents, public school educators, Planned Parenthood, and the clergy, and has demonstrated efficacy in a state with an abstinence only policy for sex and HIV prevention education. MG can be implemented as a stand-alone or component of any sex education curriculum regardless of local politics because of its focus on peer resistance and decision making. The curriculum consists of 6 brief lessons that can be taught during or after school and an interactive videogame to teach sexual pressure resistance, improve self-efficacy, and motivate resistance. However, the program targets only Latinas and technology has not adequately advanced to take the game component to scale without prohibitive costs. Hence, we propose to develop a scalable, multicultural version that relies on a narrative app, Mighty Moment, in lieu of the interactive videogame. Phase I will establish usability and appeal of the multicultural curriculum version and the app, both of which will be developed through formative work involving a multi-racial/ethnic group of 7th grade girls, and review of the evidence-based multicultural keepin’ it REAL curriculum and current literature. Additionally, the Mighty Moment app prototype will be developed in collaboration with Tapp Technologies, a leading innovator in health promotion technology. This app will guide girls in creating and narrating a story about being “Mighty” (using their “Mighty Girls” powers to resist sexual pressure without making enemies of the initiator). Phase II will evaluate MG program efficacy after incorporating social media, with girls’ stories submitted to Storybooth.Com to be selected for animation and posting on their website where such animations receive over 40 million views, creating a powerful mechanism for dissemination of peer resistance stories and intervention messages. Efficacy of the existing intervention, need for risky sex reduction interventions that surmount political barriers, and REAL Prevention’s success in commercializing health interventions through partnerships with 4-H clubs, Planned Parenthood, and D.A.R.E. America argue for the proposed project’s promise. Project findings also lay the foundation for developing a similar program for boys.

Public health relevance
This Phase I SBIR will develop and demonstrate the usability/feasibility of a multicultural adaptation Mighty Girls, an effective program for reducing risky sexual behavior among 12-14- year-old girls, that harnesses the power of mobile technology and social media using a novel story writing app. The adaptation will make Mighty Girls easily scalable as either a stand-alone or a component of school- or community-based curriculum, and capable of reaching millions of youth a year. Mighty Girls is unique from other sex and HIV prevention programs because it focuses on decision making and resisting the peer pressure that leads to risky sexual behavior, skills that are valued equally by communities that want abstinence only and communities that want abstinence plus sex education.